Beyond Treatment Initiation: Enhancing Opioid Use Disorder Care Transitions Across Health System Touchpoints

7. PROJECT SUMMARY/ABSTRACT
The opioid epidemic continues to rage, taking a vast toll on morbidity and mortality across the U.S. Despite
efforts to expand availability of life-saving medications for opioid use disorder (MOUD), a significant gap re-
mains in access to and continuity in these treatments. Given the high frequency of encounters with acute-care
settings among patients with opioid use disorder (OUD), emergency departments and hospitals are increas-
ingly seen as ‘touchpoints’ to promote initiation of MOUD treatment. Growing evidence around the efficacy of
initiating MOUD in the hospital and linking people to community treatment has led to a rapid growth of such
hospital-based interventions. However, little is known about the nature or success of strategies used to transi-
tion patients from hospital settings to community-based MOUD treatment. Knowing which transition strategies
are most effective in improving engagement in MOUD treatment post-hospitalization is critical to supporting
patients through the ‘OUD Cascade of Care’ towards reduced overdose risk and improved health.
The goal of this K01 Award is to address these gaps while advancing the candidate’s career goal of becom-
ing an independent investigator who works at the interface of intervention and implementation research, epide-
miology, and policy to advance knowledge on strategies to improve access to, uptake and sustainability of evi-
dence-based services for opioid and other substance use disorders. Through coursework, scientific confer-
ences, experiential learning, and close mentorship from experts in addiction, health services research and
qualitative and quantitative methods at the NYU Grossman School of Medicine and partner institutions, Dr.
Krawczyk will develop competency in the delivery of addiction services and acute care interventions; mixed
methods for collecting and analyzing data on healthcare practices and their implementation; analysis of multi-
level healthcare data from diverse datasets; and professional skills for grant writing and research partnerships.
The proposed research will employ quantitative and qualitative methods to study the nature and role of
transition strategies used to link OUD patients from hospitals to ongoing MOUD engagement in the community
using a case study of 11 public hospitals in NYC. Research aims are to (1) Develop a taxonomy and subse-
quent survey of hospital OUD care transition strategies via review of the literature and input from an expert
Delphi panel; (2) Conduct in-depth interviews with provider and patient stakeholders regarding primary barriers
and facilitators to effective transitions, and; (3) Explore multi-level associations between patient characteristics,
hospital transition strategies, and post-discharge MOUD engagement outcomes. This work is in line with
NIDA’s goals to conduct research that addresses real-world complexities, explores sustainable implementation
of evidence-based practices for substance use treatment, and studies the integration of treatment services in
diverse health care settings. By providing salary support, training, and a formal mentorship structure, this
award will facilitate Dr. Krawczyk’s transition to an independent career in addiction health services research.

Public health relevance
8. PROJECT NARRATIVE Opioid use disorder continues to exert a significant toll on morbidity and mortality in the U.S., yet a pervasive gap remains in engaging the most vulnerable patients in continuous use of evidence-based treatment with medications for opioid use disorder. The proposed research aims to address a lack of knowledge regarding effective strategies for transitioning opioid use disorder patients from interventions that initiate medications in hospital settings to ongoing treatment in the community. This K01 will uncover evidence to better support integrated care services for opioid use disorder across health system touchpoints, while supporting a new investigator in advancing towards an independent research career dedicated to promoting equitable access to evidence-based addiction health services.